Precision mapping of Schistosoma mansoni risk for targeted public health control and elimination

PROJECT SUMMARY
Schistosomiasis is a neglected tropical parasitic disease that infects over 150 million people in low- and
middle-income countries. WHO has targeted schistosomiasis for elimination as a public health problem by
2030 but is not on track due to geographically focal areas of persistent endemicity, especially hot spots of high
Schistosoma prevalence. After decades of the longstanding public health strategy of mass drug administration
(MDA), endemic areas and hot spots are often geographically focal and missed by the standard district-level
prevalence surveys that inform MDA decisions. More granular prevalence mapping to inform targeted MDA is
limited by: (1) inefficient diagnostics (i.e., stool microscopy) that are slow, insensitive, and prohibitively
resource intensive; and (2) lack of understanding of the optimal geographic scale (i.e., district, sub-district,
community) for mapping and MDA implementation. Our broad, long-range goal is to evaluate whether more
geographically precise mapping with newer diagnostics for targeted MDA, including more intensive efforts in
hot spots, can improve schistosomiasis control while being cost-effective. Our proposal will evaluate a novel
‘rapid mapping strategy’ that will compare two rapid, sensitive lateral flow urine antigen tests: (1) WHO
endorsed semi-quantitative POC-CCA; and (2) fully quantitative UCP-LF-CAA, in an innovative pooled
sampling strategy, which is supported by our preliminary data. Our application will leverage a decade-long,
productive collaboration in Côte d'Ivoire and includes a multi-disciplinary team that merges expertise across
epidemiology, diagnostics, mathematical modeling, cost-effectiveness analysis, clinical medicine, and policy. In
Aim 1, we will evaluate rapid urine antigen tests with pooled sampling for identification of endemic and hot spot
locations of Schistosoma mansoni prevalence for improved surveillance. We will test pooled urine samples
with two rapid antigen tests (qualitative POC-CCA, pool size 4-8; highly sensitive and quantitative UCP-LF-
CAA, pool size 5-10), using a one-stage (pooling only) and two-stage system, in comparison to WHO-
recommended thresholds for being an endemic or hot spot location. In Aim 2, we will apply a geospatial model
of S. mansoni prevalence and project the impact and cost-effectiveness of implementing surveillance, including
the rapid mapping strategies, and MDA against S. mansoni at more granular geographic scales (sub-district,
community-level), compared to current standard district-level decisions. We will develop an open-source
modeling tool to guide optimal mapping for schistosomiasis, which may be used by national MDA programs
across endemic countries. This proposal’s aim to evaluate new rapid mapping strategies to guide precise
intervention against schistosomiasis will support the 2030 WHO goal of eliminating schistosomiasis as a public
health problem.

Public health relevance
PROJECT NARRATIVE Schistosomiasis is a neglected tropical parasitic disease with ongoing efforts to achieve elimination as a public health problem through a strategy of mass drug administration. Yet how to efficiently identify focal geographic areas of Schistosoma endemicity and hot spots of high prevalence to inform targeted mass drug administration is limited. The proposed research aims to determine whether more geographically precise mapping with newer rapid urine antigen diagnostics in a sample pooling approach for targeted mass drug administration can improve schistosomiasis control efforts and be cost-effective.